Expanding the AWC Prototype with Additional Reporting and Analytics Features (Supplement to R44AG082602, Adult Wellbeing Checkup (AWC))

________________________________________________________________________________________
PROJECT SUMMARY/ABSTRACT
Overview of the funded parent award:
Parent Grant: Innovative web-based service platform called Adult Wellbeing CheckUp (AWC) to assess older
adults wellbeing, obtain evidence-based recommendations, and receive support to take action (R44AG082602)

Public health relevance
________________________________________________________________________________________ PROJECT NARRATIVE The Adult Wellbeing CheckUp (AWC) platform (funded by the parent award) will facilitate wellbeing assessments, referrals, and recommendations of American adults over 65 years of age to age well. By personalizing to the context of an individual’s life and utilizing evidence-based behavior change principles, the platform will encourage older adults to take actions to improve their individual and overall wellbeing domains. The AWC commercialization plan relies on the reporting of the AWC to be delivered such that its initial customers will pay for ongoing annual subscriptions to the service. In this supplement, we intend to expand the AWC prototype with additional reporting features and a consumer-friendly, searchable data repository. These features, which were not previously proposed, will allow senior centers (and additional customer segments) to more deeply understand the engagement as well as health of their members. By adding these features, we can also better support and enable the AWC commercialization plan.